Novel catheter treatment of structural heart and valve disease

We developed an improved transcatheter ventriculoplasty in the MIRTH (Myocardial Interstitial Reinforcement using an endovenous teTHer) procedure, which entails implanting a drawstring-like tension device circumferentially WITHIN the heart muscle, in order to shrink dilated hearts and improve their pumping efficiency. MIRTH implantation is guided by a novel electrocardiographic depth navigation technique (EDEN). Non-clinical studies in model cardiomyopathy show a reduction in ventricular volumes and improved left ventricular elastance. MIRTH has been performed on a patient by clinical partners on a compassionate basis. We are working internally and with industry to develop purpose-built MIRTH and EDEN devices; testing is ongoing towards clinic.

With our partners at Emory University, we have developed a novel ventriculoplasty to slice the beating heart. The treatment is called SESAME. It treats left ventricular outflow tract obstruction in patients with a common congenital heart disease (hypertrophic cardiomyopathy); it creates space to implant mitral and sometimes aortic valves non-surgically; it may in the future help relieve excessively-stiff hearts causing heart failure with preserved left ventricular function (HFpEF). We have helped our partners apply SESAME to the compassionate care of patients with few good options. We briefly conducted a IDE clinical protocol of this procedure but terminated the protocol after the first participant suffered a serious adverse device effect. We are working to develop a purpose-built device to accomplish SESAME more safely and to to disseminate the technology more widely.

We have obtained regulatory approval to begin enrollment in our trial of transauricular intrapericardial tricuspid annuloplasty (TRAIPTA) technique and device to treat secondary tricuspid regurgitation. We expect to enroll participants in the upcoming fiscal year.

We have developed a purpose-built device called TELLTALE designed for electrosurgical laceration of aortic leaflets in the BASILICA procedure. We designed, led, and completed enrollment in the pivotal multi-center clinical trial (NCT05666713).

We have developed a novel technique to access deep myocardial targets that contribute to life-threatening ventricular arrhythmia, especially the VINTAGE procedure. We have developed the technique in animals and are helping clinical collaborators offer VINTAGE as the practice of medicine to help patients who lack good alternatives. Two dozen patients have undergone the procedure to date.

We are developing other novel procedures and devices to address important unmet clinical needs.

Other techniques developed in the laboratory continue to be adopted worldwide, including transcaval access, LAMPOON mitral leaflet laceration, and BASILICA aortic leaflet laceration.